Clinical Brain Tumor Development of a Cytomegalovirus-targeted Therapeutic with Vaccine pre-conditioning to Validate Novel Predictors of Vaccine Efficacy

ABSTRACT
We have previously reported in Nature that patients with newly-diagnosed glioblastoma (GBM) randomized to
receiving vaccines against Cytomegalovirus (CMV) using a potent vaccine site preconditioning regimen had a
statistically significant increase in progression-free survival (PFS) and overall survival (OS). Half of the patients
treated this way were still alive nearly 5 years later despite having no genetic markers predicting long-term
survival. These results have been repeated in an additional cohort which showed a median survival of 44.1
months with ~36% of patients alive at 5 years. These results are remarkable because GBM remains uniformly
lethal with a median OS of < 21 months despite surgical resection, high dose radiation therapy, chemotherapy,
and tumor-treating fields, and only 10% of patients typically live past 5 years.
In addition to demonstrating the potential for efficacy, our preliminary clinical and laboratory studies
demonstrated that preconditioning the vaccination site with tetanus/diphtheria (Td) recall antigens increased DC
migration to the draining lymph nodes (DLNs), which predicted PFS and OS as did the production of
polyfunctional, CMV-specific T cells. These T cell responses were enhanced by GM-CSF at the vaccine site and
pre-vaccination lymphodepletion with standard of care (SOC) temozolomide (TMZ), but inhibited by subsequent
adjuvant doses of TMZ. Moreover, mechanistic studies in mice and humans revealed that efficacy was also
dependent on producing high systemic levels of the chemokine (C-C motif) ligand 3 (CCL3).
We believe these results warrant confirmation in a larger series of patients.
Our Specific Aims are:
1. To conduct a larger Phase 2 trial of CMV pp65-loaded DC vaccination in patients with GBM. Patients
with CMV positive, newly diagnosed GBM will receive serial vaccines with CMV pp65-loaded DCs with GM-CSF
and Td vaccine site preconditioning. GM-CSF and Td vaccine site preconditioning will be employed because
they have been shown to enhance DC migration and increase polyfunctional T cell responses in prior studies.
TMZ will be given prior to vaccination to induce homeostatic proliferation of the vaccine-induced T cell responses
but not given subsequently to prevent killing of vaccine-induced T cells.
2. To confirm predictors of survival. In our prior studies DC migration to draining lymph nodes, systemic and
local CCL3, and CMV pp65-specific polyfunctional T cells predicted PFS and OS. Here we will collect samples
to confirm these predictors.

Public health relevance
NARRATIVE Glioblastoma, the most common form of primary brain tumors, remains uniformly lethal with conventional treatments and is the most frequent cause of cancer death in children and young adults. In studies with limited patient numbers we have recently shown that a vaccine treatment using the patient's own cells and parts of the virus CMV may be effective treatment for these fatal illnesses. We now wish to do a larger study to confirm these results.